Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core will provide the structure for effective and efficient operation and maintenance of the
Washington University Advancing Cancer Control Equity Research through Transformative Solutions (WashU-
ACCERT), while engaging with community and leveraging innovative opportunities to promote cancer control
equity. The Administrative Core will support an environment of research excellence, scientific innovation,
community engagement, and transdisciplinary scholarship within WashU-ACCERT and among other centers of
the NCI ACCERT consortium. The Administrative Core will manage and coordinate all WashU-ACCERT
operational and scientific activities, within a cohesive organizing framework, including fiscal management,
evaluation, communication, and dissemination to advance cancer control equity by stimulating community-
engaged, multilevel research that address the impact of social determinants of health (SDOH) on adverse
cancer control outcomes.
The Administrative Core will support the overall mission of the WashU-ACCERT through the following aims: (1)
Envision and sustain the operational structure, scientific leadership, and community engagement for WashU-
ACCERT to maximize efficiency, effectiveness, and accountability; (2) Service in leadership that results in
dissemination, collaboration, and networking within WashU-ACCERT and across the consortium of centers,
including the coordinating center; (3) Cultivate and champion capacity building among diverse scholars and
community partners; (4) Evaluate all WashU-ACCERT activities and provide feedback to refine ongoing
activities; (5) Establish a timeline and milestones to monitor progress and coordinate efforts. The leadership,
operational structures and processes of the Administrative Core will position WashU-ACCERT to engage with
community across Missouri and Illinois to conduct high-quality, high-impact science and to improve access to
care and reduce cancer disparities.
The WashU-ACCERT investigators have substantial expertise and a proven track record in conducting
collaborative, community-engaged health equity science in cancer control, including multi-level interventions
addressing social determinants of health as well as in disseminating findings to researchers and the
community. We will advance the field of cancer control research drawing from our Center’s distinctive features
that include a record of cancer disparities research, rigorous community engagement, and the application of
strategies to conduct rapid-cycle studies. The Administrative Core is a critical element of the overall scientific
program and infrastructure for the Center and provides a strong foundation for scholarly excellence, research
synergy, and clinical and community impact.